T CELL RECEPTOR REPERTOIRE AND SUPERANTIGENS IN RHEUMATOID ARTHRITIS

Rheumatoid arthritis (RA) is an autoimmune disease of unknown etiology characterized by chronic inflammation in multiple joints. It is estimated that the prevalence of RA is 0.8%, making it one of the most common autoimmune diseases and the most common cause of inflammatory arthritis. In a significant fraction of patients, the chronic arthritis leads to destruction of the joint cartilage and surrounding joint structures. RA is a major cause of disability and morbidity.